Endothelial Cell Estrogen Receptor Alpha-mediated Mechanisms of Protection from Atherosclerosis Inflammation in Females

PROJECT SUMMARY/ABSTRACT
Enhanced understanding of sex-specific mechanisms driving cardiovascular disease (CVD) is necessary to
develop precision strategies to prevent CVD, the leading cause of death for men and women. Heart attack and
stroke are most often caused by the rupture of inflamed atherosclerotic (athero) plaques. Athero plaques develop
from endothelial cell (EC) damage that induces expression of adhesion molecules (AMs), including intracellular
AM 1 (ICAM1), E-selectin (Esel), P-selectin (Psel), and vascular AM 1 (VCAM1), resulting in leukocyte
recruitment causing inflamed plaques. Women are protected from CVD relative to men, and our lab found that
female athero-prone mice have reduced athero plaque inflammation compared to males, suggesting that females
may be protected from CVD events by decreased plaque inflammation. Since CVD risk increases in women after
menopause, estrogen (E) and estrogen receptors (ERs) have been implicated, yet the detailed mechanism
remains unknown. Indeed, E treatment in postmenopausal women has been shown to reduce CVD events when
began <10 years post-menopause. Prior studies suggest that ERs may regulate known drivers of EC
inflammation. Specifically, (1) our lab showed that ERa inhibits mineralocorticoid receptor (MR) transcriptional
activity in vitro and (2) prior studies show that ER can inhibit the pro-inflammatory transcription factor nuclear
factor kappa B (NFkB), a known activator of AM expression. Whether these mechanisms contribute to protection
from athero inflammation in females remains a gap in knowledge. Therefore, we propose to test the hypothesis
that EC-ERa protects against athero inflammation in females by downregulating AM expression via distinct MR
and NFkB-mediated mechanisms. In Aim 1, we test the hypothesis in vitro that EC-ERa inhibits AM expression
by preventing EC-MR and NFkB binding to AM promoters, thus attenuating leukocyte adhesion to ECs. To test
this, ER expression and activity will be modulated in primary human aortic ECs from women using ERa siRNA
knock-down +/- ERa agonism with E2 and we will measure (1) ERa, MR, and NFkB enrichment on AM promoters
by chromatin immunoprecipitation (ChIP)-PCR, (2) AM expression by PCR and immunoblot (IB), and (3)
adhesion of fluorescent leukocytes to ECs. In Aim 2, we test the hypothesis in vivo that EC-ERa inhibits AM
expression and protects from athero inflammation in females using three novel cell-specific knock-out mouse
models in which ERa, MR, or both ERa and MR are specifically deleted in ECs and crossed to the athero-prone
low-density lipoprotein receptor background. In female mice, we will measure (1) leukocyte trafficking by intravital
microscopy, (2) plaque composition by histology, (3) AM expression by PCR and IB, and (4) ERa and NFkB
enrichment on AM promoters in aortic tissue after 12 weeks of high fat diet. Successful completion of these aims
will elucidate EC-ERa-mediated pathways that regulate AMs and leukocyte trafficking thereby clarifying
mechanisms by which young females are protected from CVD. The detailed training plan will prepare the PI for
a career as an independent physician-scientist studying mechanisms driving sex differences in human disease.

Public health relevance
PROJECT NARRATIVE Heart attack and stroke are the leading cause of death for both sexes. Young women are protected from heart attack and stroke relative to age-matched men but ultimately, women exceed men in these risks when they become old; this has suggested a role for the hormone estrogen, but we still do not know how this hormone protects young women. The overall goal of this proposal is to reveal mechanisms by which one of the estrogen receptors that is present in the cells lining blood vessels can protect females from hardening of the arteries and inflammation of the blood vessels which causes heart attacks and strokes.